Arsenic suppresses progesterone receptor signaling and promotes tamoxifen resistance and metastasis of ER+ breast cancer

SUMMARY
The central concept in this project is that exposure of existing estrogen receptor (ER) and
progesterone (PR) positive (ER+/PR+) breast tumors to heavy metal pollutants promotes the
emergence of tumor cells that lack PR expression and function. While ER+/PR+ breast cancer
have excellent prognosis and respond well to treatments, ER+/PR- do not and often progress to
highly lethal recurrent metastatic disease. Hence, we propose that environmental arsenic,
cadmium, lead or mixtures of these metals present in particulate air pollution and water supplies,
poses a grave risk for the successful treatment of women with ER+/PR+ breast cancer via
promoting the reprogramming of these tumors to ER+/PR- phenotypes. In addition, we found that
phenotypic reprogramming by heavy metals involves changes in the cellular nuclear redox state.
As reactive oxygen species (ROS) increase in the nucleus, vastly because of heavy-metal
induced mitochondrial dysfunction, progesterone receptor gene expression is suppressed
unleashing phenotypic reprogramming. We also found that quenching these ROS at the origin
(mitochondria) or in the nucleus (site of action) reverses the suppression of PR expression by iAs,
Cd and Pb and to a large extent resensitizes metal-transformed breast cancer cells to the anti-
neoplastic action of first line selective estrogen receptor modulators, often the most accessible
therapy for low income and minority populations. Since, we now have FDA-approved, as well as,
novel proprietary compounds to suppress nuclear ROS in tumor cells, this strategy may lead to
much needed adjuvant therapies to mitigate some of the most devastating health effects of heavy
metal contaminants disproportionately affecting low income and minority breast cancer patients.
Therefore the goals of this project are: 1) Determine how nuclear ROS-driven epigenetic
reprogramming impacts ER+/PR+ tumor transitions to treatment refractory ER+/PR- phenotypes;
2) Determine if suppressing ROS in the nucleus restores treatment effectiveness in xenograft
tumor models of metal-transformed cells; 3) Determine if FDA-approved pharmacologic
mitochondrial ROS scavengers are effective in resensitizing metal-transformed tumor cells to
SERMs. We propose that finding pharmacologic ways to mitigate some ofthe detrimental health
effects of exposures to heavy metals may be an urgent short term solution to reduce
environmental health disparities.

Public health relevance
NARRATIVE Heavy metal pollution by arsenic (iAs), Cadmium (Cd) and lead (Pb) disproportionally affects low income communities and minority groups nationally and internationally. We found that these metals alone and in combination, at doses much lower than the World Health Organization (WHO) recommended limits, cause epigenetic reprogramming of treatment responsive ER+/PR+ breast cancer to ER+/PR- treatment refractory disease. As nuclear ROS were found to be mechanistically linked to PGR downregulation this project proposes to test new and existing strategies based on organelle-targeted ROS scavengers as adjuvant therapeutics to restore treatment efficacy thereby providing short term pharmacologic solutions for patients impacted by socioeconomic and environmental health disparities.